Invisible Evictions: Displacement Pressures and Mental Health

PROJECT SUMMARY/ABSTRACT
The parent award (R01NR021156) focuses on the mental health trajectories of two groups of adult renters who
were threaten with eviction: (1) those who received an eviction filing and (2) those who were at-risk for eviction
but did not receive a court-ordered eviction filing. Household that receive an eviction filing are at risk for a hard
displacement. Households that are at-risk for an eviction but did not receive a court-ordered eviction filing are in
a tenuous housing status and feel a “pressure to move” to avoid hard displacement. Among households that feel
pressure to move, there are some that 1) move (i.e. soft displacement), while 2) others stay yet continue to feel
the pressure to move (i.e. potential displacement). These 2 groups of marginalized renters cannot be tracked
through the court systems, and less is known about them. Thus, an important supplement to the parent award's
efforts is to conduct a closer examination at tenants who felt the pressure to move and experienced soft or
potential displacement. The proposed supplement employs a mixed methods sequential explanatory design, just
like the parent award. For aim 1, the baseline and time 2 survey from the parent award will be used to examine
the direct and indirect associations between (soft vs. potential) displacement, economic hardship, psychosocial
stressors, and mental health. The goal of aim 2 will be to gain new data that will inform how and why the positive
associations in aim 1 exists, along with pinpoint barriers and facilitators not identified in survey through focus
group and photo elicitation interviews with a subset of tenants (n=40). The supplement also provides a wonderful
opportunity to concurrently provide training to first-generation early-career scholars to strengthen their research
skills. The PI, a first-generation Latina college graduate, has a strong track record of recruiting and mentoring
first-generation college graduates that includes being the PI of $1.2 million in training grants and opportunities.
Through this supplement, two trainees will engage in a series of online webinars and didactic courses to facilitate
content and methodological expertise, a professional development seminar, and applied research experiences
through the proposed research study. The trainees will also disseminate the findings associated with this
supplement through conference presentations, publications, and a photography exhibit. Last, trainees will
provide mentorship to first-generation undergraduate students. The short-term outcomes of the training program
include, but not limited, to trainees increasing their research self-efficacy and serving as role models to first-
generation undergraduate students. Building on the NINR-funded research occurring at the Cizik School of
Nursing (CSON), the long-term outcomes includes establishing CSON as having a strong training program
focused on the social and structural determinants of health across communities affected by homelessness and
displacement. The program's impact contributes to a more diverse workforce in behavioral research and an
increased accrual of health disparities research studies. These studies have the potential to improve housing
policies and social services designed to reduce displacement pressures and poor mental health.

Public health relevance
PROJECT NARRATIVE Tenuous housing relationships with landlords/property managers can increase feelings among tenants that they must move, resulting in a group of tenants to move (i.e. soft displacement), while another group of tenants stay yet continue to feel the pressure that they must move (i.e. potential displacement). Less is known about these two groups of marginalized renters since there is no court ordered eviction notice attached to their displacement; however, data from the parent award and new data gained through qualitative interviews provide the opportunity to do an in-depth investigation of how (soft vs. potential) displacement, economic hardships, psychosocial stressors, and other decision-making processes contribute to mental health disparities. The supplement also provides the opportunity to support two first-generation college graduates to strengthen their research skills and serve as role models for first-generation college students.